PROVIDE NEW INSIGHTS IN ALPHA-SYNUCLEIN INDUCED CELL MEMBRANE DISRUPTION USING SCANNING ION CONDUCTANCE MICROSCOPY AND SURFACE PLASMON RESONANCE MICROSCOPY

Abstract:
Parkinson’s disease (PD) is a leading neurodegenerative disorder attributed to the abnormal folding and
aggregation of alpha-synuclein (α-syn) in dopaminergic neurons. The exact causative mechanism, however,
remains unclear. Leveraging advanced techniques like scanning ion conductance microscopy (SICM) and
surface plasmon resonance microscopy (SPRM), our previous work elucidated how α-synuclein oligomers might
compromise neuronal membranes, while pre-formed fibrils (PFFs) primarily influence membrane roughness
without inducing significant cytotoxicity. This new phase aims to deepen our understanding by exploring the role
of phosphorylated α-syn (P-syn), a pathological variant of α-syn. The objectives include synthesizing and
characterizing P-syn, assessing its impact on neuronal membranes, and evaluating its influence on iron-driven
dopamine oxidation. Furthermore, we will investigate the role of environmental toxins, specifically nanoplastics,
in α-syn aggregation and its subsequent interactions with membranes. The outcomes from this research are
anticipated to shed light on the molecular intricacies of PD and potentially pave the way for targeted therapeutic
strategies.

Public health relevance
Narrative Parkinson's disease (PD) is a chronic and progressive movement disorder, affecting one million people in the U.S. Our goal is to investigate the interaction between alpha-synuclein aggregates and neuronal membranes, which is believed to play an important role in PD development and progression. Such information will facilitate the ultimate development of the PD treatment modality.